Ribonucleoprotein Biogenesis and Epigenetic Gene Regulation

Abstract
The research in our laboratory centers on foundational mechanisms that regulate eukaryotic gene expression.
In particular, we are interested in roles played by small nuclear ribonucleoproteins (RNPs) and histone post-
translational modifications (PTMs) in the transmission of genetic and epigenetic information required for proper
metazoan development and genome function. We have developed innovative model systems in Drosophila
melanogaster to study gene regulation and neuromuscular disease. Critically, these models allow direct
interrogation of specific residues present within conserved genes and multi-gene families. For example, we can
now study the biological function of a specific histone PTM by changing the acceptor residue to an amino acid
that cannot be appropriately modified and then replacing all wild-type copies of a given histone gene with mutant
copies. This approach is not possible in other animal models. Hence, for the first time in any multicellular
eukaryote, we can now directly determine the extent to which a given histone PTM contributes to cell fate and
organismal development. Similarly, we generated an allelic series of animals that express missense mutations
in the Survival Motor Neuron (SMN) gene that are derived from human Spinal Muscular Atrophy (SMA) patients.
This series represents the largest number of SMA-causing point mutants currently available in any model
organism. Several of these alleles serve as separation-of-function mutations that uncouple the putative
housekeeping and tissue-specific activities of SMN, enabling us to study these processes independently. We
employ genome-wide techniques together with molecular genetics and biochemistry to identify cellular pathways
and binding partners that are dysregulated in human cancer and neuromuscular disease. Using these two
powerful genetic platforms, we expect to identify factors and mechanisms that enable a specific chromatin mark
to modulate the expression of an individual transcript or an entire chromosome, as well as those that carry out
the assembly and maturation of spliceosomal and messenger RNPs.

Public health relevance
Project Narrative This proposal takes advantage of innovative model systems to address connections between eukaryotic chromosome packaging, ribonucleoprotein assembly and pre-messenger RNA processing. Work here is expected to fundamentally advance our understanding of epigenetic gene regulation and neuromuscular development, providing critical insight into molecular mechanisms that drive Cancer and Spinal Muscular Atrophy in humans.